Mechanisms of chromatin and transcriptional regulation

Abstract of Parent Award
Our long-term goal has been to reveal the molecular mechanisms of histone-modifying
enzymes, histone chaperones and other transcriptional regulators that control genome
function. Many of the proteins and their modifications we study are dysregulated in human
disease, including cancer. Despite considerable progress by our lab and others, crucial
knowledge gaps remain in our fundamental understanding of chromatin regulation. With
the renewal of this MIRA award, we will continue our studies into the function of chromatin
regulators and address three of the foremost fundamental questions in chromatin biology:
1) How do histone-modifying enzymes and chaperones contribute to chromatin
organization and gene transcription? 2) How do more recently discovered histone PTMs
and reader domains contribute to gene transcription? 3) What are the rules by which
histone readers engage nucleosomes and how do these binding events regulate
downstream events in chromatin? For each question, we highlight several examples of
the types of studies we are pursuing and describe how they will advance the field.

Public health relevance
PARENT PROJECT NARRATIVE Defects in chromatin organization, gene transcription, and DNA packaging are major causes of human disease, notably cancer. Our studies will uncover the functions of readers and writers of histone post-translational modifications and histone variants, as well as the function of a histone chaperone complex. These studies will advance our fundamental understanding of the chromatin regulators that are dysregulated in human disease, thereby identifying new targets for therapeutic intervention.